Older Americans Independence Center

Overall: Project Summary
This is a renewal application for the Johns Hopkins University Older Americans Independence Center (JHU
OAIC). In the current cycle dating to 2018, this OAIC has nurtured extensive accomplishment, contributing to
150 publications and findings that facilitated the funding of 35 additional grants focused on frailty and aging.
Investigators in this OAIC seek to promote independence in older adults through the study of the etiologies and
clinical ramifications of frailty and through the translation of this knowledge into the development of novel,
frailty-focused diagnostic, treatment, and prevention strategies. This proposal’s specific aims to achieve these
goals are: 1) Stimulate and develop effective frailty-focused interdisciplinary research programs; 2) Translate
the frailty-focused knowledge generated into targeted prevention and treatment strategies that help older
adults maintain independence; 3) Provide focused and accessible frailty-related training and mentorship to
junior investigators interested in developing careers aiming to maintain independence in older adults; 4)
Provide to OAIC-supported investigators the highest quality inter-disciplinary expertise and infrastructure in
biostatistical, biological, and clinical science—and, new to this cycle, also in engineering and technology; 5)
Support the development of innovative methodologies, research strategies and technologies essential to the
study of frailty; and 6) Attract outstanding investigators and trainees to frailty research from across JHU and
promote visibility of their science locally and nationally. A Research Education Component and Pilot /
Exploratory Studies Core will provide training, mentorship, and both advisory and material support for research
projects for supported investigators. Highly integrated resource cores focused on biostatistics, biological
mechanisms, clinical translation / recruitment, and technological assessment / solutions will provide supported
investigators with the interdisciplinary expertise, training, mentorship, assistance, and services necessary to
perform outstanding frailty-focused basic, clinical and translational research. The Leadership and
Administration Core will provide scientific visioning, administrative and regulatory oversight, and will also guide
the dissemination of frailty research through our frailty science website, social media, innovative educational
initiatives, embedding in the OAIC network, partnerships with scientific and professional organizations,
formation of communities of practice, and outreach efforts. Woven throughout the whole is an intensified focus
on health equity. This OAIC will continue to be directed by a long-standing, interdisciplinary, accomplished, and
highly visible leadership team who will develop an ongoing vision for the next generation of frailty science and
have worked to build a scientifically and culturally diverse community of scholars and trainees around frailty.
This team is dedicated to developing the next generation of needed scientific advances and disseminating
resulting strategies into practice and policy that extend independence and improve health for millions of older
adults.

Public health relevance
Overall: Project Narrative Frailty is an age-related syndrome of multisystemic decline which confers vulnerability to many other adverse outcomes including loss of independence. This OAIC is designed to foster high quality research which will identify etiologies of frailty and develop clinical and prevention strategies that will improve function, health and independence for millions of older adults.